EVALUATION OF NEW MINI-NEEDLED INJECTION DEVICE

The primary objective of this pilot study is to examine injection quality, pain, bruising, and bleeding after injections with one or two new mini-needled injection device(s) as compared to one device. Normal subjects aged 18-70 will be enrolled. The study will take place on two visits. On visit 1, subjects will receive 12 injections over a period of approximately 15 minutes. On visit 2, subjects will have injection sites evaluated. We are requesting permission to use outpatient rooms at the GCRC for visit 1.